The Effective Parenting Program (EPP): An Integrated Stress Reduction and Parenting Intervention for Families of Children with Developmental Disabilities

Project Summary ! Parents who have children with developmental disabilities (DD) commonly experience high levels of stress related to child behavior problems and contextual issues related to the child's disability that can have a detrimental effect on their parenting. Current stress management programs for this population of parents often do not lead to a reduction in children's behavior problems and Behavioral Parent Training programs (BPT) do not always lead to a reduction in stress. Interventions that combine the two approaches are more effective, providing substantial benefits to both parent and child. The central goal of this project is to create an online, interactive stress reduction and BPT program: The Effective Parenting Program (EPP): An Integrated Parenting Intervention for Families of Children with Developmental Disabilities. We propose three Specific Aims with the primary aims of reducing parents' stress and strengthening parents' parenting efficacy and psychological flexibility. Our secondary aims are designed to answer questions regarding (a) the influence of changes in parents' efficacy and psychological flexibility on child behavior and (b) the role of parents' attention to and awareness of present moment experiences. This work is significant because it will provide resources for an underserved population - parents of children with DD -- who experience frequent stress with the challenges of raising a child with DD and who may lack basic behavioral parenting skills. Moreover, the proposed program has the potential to broadly impact the way supports are delivered to parents of children with DD by adding an integrated, efficacious intervention that overcomes common barriers to parental participation (time, finances, and availability). From a public health perspective, this approach is ideally structured to meet the needs of this population of parents who are in need of easy to implement and cost effective support and training. Upon completion in Phase II, parents will have access to a complete EPP program, designed to help them cope with stress more effectively and strengthen their behavioral parenting skills. The program will provide parents with engaging, interactive content, including: tools for monitoring progress, text prompts and incentives to motivate behavior change, a mechanism for the sharing of social support, guidance in setting effective value-based goals, strategies for reducing stress, and training in evidence-based parenting skills. The EPP program will be available on a mobile website that can be accessed by smart phones, tablets and computers and will provide realistic situational videos vignettes, workbook exercises and a discussion forum to help parents deal effectively with stress and challenging behaviors. In Phase I of this project, we will determine the feasibility of the program by examining primary and secondary outcomes related to a prototype of the EEP program. !

Public health relevance
Project Narrative Currently available interventions for parents of children who have DD are either group-based or require home visits which are expensive to implement and difficult to access. And, while there are a number of efficacious interventions that focus on either handling stress effectively or behavioral parent training, each approach alone has significant limitations. There is a need for an integrated approach giving parents of children with DD low cost, immediate access to the help and support they need. This project addresses a significant public health need by developing and evaluating a low- cost, accessible online integrated stress reduction and parent behavioral training program that can be easily implemented by parents in this population to reduce their stress and strengthen parenting skills.